Towards a genome-wide CRISPR/Cas9 mutant library in Rhizopus delemar

Rhizopus delemar is the primary cause of life-threatening mucormycosis
responsible for
approximately 70% of clinical cases, with an overall mortality rate exceeding 50%. Despite its
devastating impact on human health,
much of R. delemar’s pathobiology and molecular disease
mechanisms remains unknown. As an initial step towards constructing a high-throughput genome-wide
mutant library of R. delemar, we propose
to generate a small-scale targeted mutant library utilizing
multiplex CRISPR/Cas9 technology. In Specific Aim 1, we will synthesize a collection of single-guide
RNAs (sgRNAs) targeting 40 randomly selected genes and deliver pooled sgRNAs and Cas9 in a one-
vector construct into R. delemar. In Specific Aim 2, we will identify gene mutations using Sanger DNA
sequencing and high-throughput next-generation sequencing. We will also assess efficacy, specificity,
and off-target mutations induced by multiplex CRISPR/Cas9. The success of this exploratory research
effort will lead to the construction of whole-genome CRISPR/Cas9 mutant libraries for the systemic
examination of R. delemar pathogenesis mechanisms.

Public health relevance
Narrative: Rhizopus delemar is the primary cause of life-threatening mucormycosis in patients with immunodeficiency. Genetic tools and research resources are urgently needed to study the molecular mechanisms of mucormycosis . We propose to generate a small-scale targeted mutant library utilizing multiplex CRISPR/Cas9 technology that can lead to the future construction of high-throughput genome- wide mutant libraries in R. delemar.